Alabama State University-Auburn University Partnership to Promote Diversity in Aging Research

Project summary: In the US, aging related diseases and health disparities are frequently observed; the
differences in disease incidence and outcomes are thought to reflect the interplay of socioeconomic factors,
access to health care, culture, diet, the environment, and population-specific genetics/biology. To address this
issue, educational and socio-behavioral changes are needed. These changes can be facilitated by diversifying
the aging related research and educational workforce. Moreover, the rapid growth and accumulation of
specialized knowledge in today’s biomedical fields, combined with health issues that persist among certain
groups within the US population, emphasize the need to diversify this workforce. Based on national statistics,
the numbers of PhD graduates from underrepresented backgrounds are low and have not changed appreciably
over three decades, despite efforts from various funding agencies, including the NIH. Several national reports
point out factors that challenge underrepresented students in graduate and biomedical programs in achieving
terminal degrees. Therefore, we propose to build an Alabama State University (ASU)-Auburn University
(AU) R25 Partnership to provide aging focused educational modules and to expose underserved
students to a summer research experience, thereby accelerating the development of scientists/health
care providers from underserved backgrounds. By leveraging the educational and research infrastructure of
the AU (Auburn, AL) and educational programs of Historically Black College and University (HBCU)-minority-
serving ASU (Montgomery, AL), we have developed a persistent, multi-faceted strategy, combining
multidisciplinary and inter-institutional education and basic aging related research projects, to train
undergraduate students from underrepresented communities. The proposed aging education and research
experience will be available to rising juniors and rising seniors majoring in biomedical disciplines. As part of this
R25 program, introductory aging related educational modules (online module development) and basic research
training will be offered to selected students at ASU during academic year while aging research experiences will
be provided at the AU. Each year, the program will support 10 students (recruited from ASU). During academic
year with continuous and consistent engagement, the selected students at ASU will participate in enrichment
activities, including education; mentoring (research and pre-professional); scientific writing seminars; technical,
bioethics, and scientific workshops; and training for presentations. During summer, these students will perform
aging related research at AU for 10 weeks. Each year, all students will make presentations during either a reginal
or national Scientific Symposium. In summary, this proposed program at ASU and AU will train students from
underrepresented communities and advance the national goal of increasing diversity in the US biomedical
sciences workforce, particularly in aging research.

Public health relevance
Project narrative: Prior reports have demonstrated that the engagement, capacity, and continuity approach has been effective in retaining and motivating students from underserved backgrounds in Medicine, Science, Technology, Engineering, and Math (MSTEM). The primary purpose of the proposed undergraduate research experience proposal is to encourage development of scientific research skills, students will be exposed to aging related educational and research preparation at Alabama State University (ASU), a Historically Black College and University, and research experience at the Auburn University, a major research University. This opportunity will enable students to interact with faculty, staff, graduate students, and postdoctoral fellows and enrich their education in aging related disciplines, and preparing them for graduate school.